Harnessing Sleep and Biological Rhythms to Improve Postoperative Recovery

PROJECT SUMMARY/ABSTRACT
Up to one-third of older U.S. adults may not return to functional baseline six months after major surgery, with
postoperative pain being one of the most significant contributors. At the same time, over a third of the adult
population also suffer chronic sleep problems, which are even more prevalent in the 3.5 million adults who will
require total knee arthroplasty (TKA) by 2030. Despite evidence-based treatment, perioperative sleep
optimization represents a missed opportunity for improvement. One challenge is that the underlying mechanisms
of how sleep impacts postoperative recovery remain a significant knowledge gap.
Recent evidence suggests poor sleep health may impact pain via the nervous system and gut
microbiome. Major surgery is a significant stressor, and habitual sleep disruption results in changes to
metabolism, neuroinflammation, or the nervous system that increase the pro-nociceptive response to this stress.
The gut microbiota influences host homeostasis for these processes, and insomnia can disrupt the gut-brain
axis. Sleep health metrics of low sleep efficiency and poor daytime alertness were linked to increased blood
homocysteine and IL-6 levels and decreases in the short-chain fatty acids-producing microbiota. At the same
time, gut microbiome composition is altered in chronic pain conditions. Thus, the gut microbiome may mediate
the influence of sleep on pain and serve as a target for adjuvant therapy for both pain and insomnia.
My research program has built a unique translational perioperative sleep infrastructure for prospective
studies and randomized efficacy trials. We focused on developing feasible and scalable at-home methods to
estimate multi-dimensional sleep and circadian phenotypes before surgery using wearable actigraphy watches
and other portable home devices. We have also collected blood to verify the circadian phase (internal time) using
transcriptomic assays utilizing the circadian nature of transcriptomes. We propose using these preoperative
sleep/rhythm phenotype measures to optimize surgical recovery. This is my area of expertise; I am an
anesthesiologist with formal training in sleep/circadian biology, computational neuroscience, behavioral and
psychosocial clinical trials, and translational studies in post-surgical pain and cognition outcomes.
This research plan will aim to understand the mechanisms of how preoperative sleep/circadian
disturbances may impact recovery outcomes through systemic changes in the gut microbiome and related
metabolic factors. To address this, we propose 1) a longitudinal study (pre- to 1-year post-surgery) with rich
phenotyping to understand the sleep-gut-pain relationships in TKA patients and 2) a randomized mechanistic
trial with a well-known non-pharmacological intervention (CBT-I) to test whether intentionally altering real-world
sleep conditions improves microbiome features. This may help us better risk stratify surgical patients and gain
mechanistic inferences to novel mechanisms that inform therapeutic targets.

Public health relevance
PROJECT NARRATIVE Sleep problems that affect the body’s natural 24-hour cycles regulating all our body’s functions, known as circadian rhythms, have been linked to postoperative pain, poor functional recovery, and cognition, which could affect millions of older adults undergoing surgery every year. This unique prospective longitudinal cohort study and randomized mechanistic trial will track sleep/circadian health, gut microbiome markers, and postoperative pain before and up to a year after surgery to establish modifiable risk factors and to use a behavioral sleep intervention to test causal effects on gut microbiome and explore potential improvements on pain. This addresses a critical public health need, potentially improving surgical outcomes and long-term health in older adults.